Anti-Malarial Drug Leads from Fungi

Project Summary
There is a need for new antimalarial drug leads, particularly for treating drug resistant malaria. Fungi have been
the source of many drug leads, with penicillin and the statins as two of the most prominent examples. We
hypothesize that fungi harbor antimalarial drug leads, and we are addressing this via a team with expertise in
mycology (Mycosynthetix/Pearce), natural products chemistry (UNCG/Oberlies), and parasitology/malaria
(UGA/Kyle).
In the examination of 40,000 fungal cultures from the Mycosythetix library, we have implemented biological and
chemical protocols to prioritize our efforts. In doing so, we have now selected 8 fungal cultures that have potent
antimalarial activity, minimal cytotoxicity to mammalian cells, and do not biosynthesize common nuisance
compounds (i.e. mycotoxins). That averages to the analysis of ~1 fungal culture per quarter over this 2 year
project. Our team is poised to isolate, elucidate, and evaluate antimalarial drug leads from these cultures. In
addition, we will prioritize the 1 to 2 best leads, such that ample materials are produced for more in depth
biological evaluation.

Public health relevance
Project Narrative Unfortunately, malaria is still a killer, and new drug leads are needed, particularly for drug resistant forms of the disease. The history of drug discovery is loaded with many leads that are derived from fungi, with penicillin being probably the most prominent. Our team proposes to study fungal cultures as a source of new antimalarial drug leads, focusing on our top 8 leads, which emerged after examining a library ~ 40,000 cultures.